Characterizing a feedback signal balancing lipopolysaccharide and glycerophospholipid synthesis in Gram negative bacteria

ABSTRACT
Due to increasing antibiotic resistance, infectious bacteria once again pose a direct threat to health. Gram-
negative pathogens are particularly dangerous as these organisms are intrinsically resistant to many antibiotics.
This resistance arises from the asymmetric outer membrane of the Gram-negative cell envelope, with
glycerophospholipids (GPL) in the inner leaflet and lipopolysaccharides (LPS) in the outer leaflet. The
impermeability of the outer membrane is however extremely vulnerable to imbalances between synthesis and
transport of GPL and LPS. Still, there remains a major gap in our understanding regarding how the cell enforces
the appropriate GPL/LPS balance.
Recent findings in Escherichia coli point to two proteins, YejM and YciM, that use LPS transiting through the
periplasm (periplasmic LPS) as a homeostatic signal to regulate the proteolysis of LpxC, the key enzyme in LPS
synthesis. We hypothesize that many signals proposed previously must indirectly modulate LpxC proteolysis by
altering periplasmic LPS levels, and thus are detected through the YejM-YciM system. In Aim 1, we will continue
our development of a novel analytical tool for quantifying LPS transport intermediates, including periplasmic LPS.
Parallel quantification of LpxC and LPS metabolic precursors by mass spectrometry will elucidate the kinetics of
the YejM-YciM system and identify the influence of upstream metabolism on LPS synthesis and LpxC
degradation. Aim 2 will investigate whether previously reported stimuli (e.g. exogenous fatty acids, envelope
stress) that alter LPS synthesis also work via the YejM-YciM signaling system. Our findings will potentially clarify
our understanding of GPL/LPS balancing by indicating that periplasmic LPS acts as the main regulator of LpxC
proteolysis. Furthermore, the data-drive quantitative models developed here can be used to predict effects of
antibiotics on cell envelope integrity. The YejM-YciM regulatory system is found in numerous pathogens,
therefore our findings will be broadly applicable. Furthermore, the tool can be used to determine whether
periplasmic (or cytoplasmic) LPS plays a role in Gram-negative pathogens that lack the YejM-YciM system.

Public health relevance
PROJECT NARRATIVE Much like armor, Gram-negative bacteria (e.g., Escherichia coli) have a unique outer surface that prevents the use of many antibiotics making infections caused by these organisms extremely difficult to treat. This proposal will help determine the molecular machinery used by Gram-negative bacteria to assemble their outer surface and identify new targets for antimicrobial design.